C type Lectin Pathway Regulates Macrophage Immune Metabolism in Mtb-Infected Lung

ABSTRACT
Pathogen recognition receptors (PRR) pathways are critical for integrating the complex microbial stimuli
encountered by innate immune cells to direct the appropriate host response. Among these PRR systems, the C
type lectin (CLR) responses are the least understood. CLRs are abundantly expressed by many myeloid cell
populations and perform a growing list of roles in recognition, internalization, and inflammatory response
regulation following host exposure to microbial insult. These recognition pathways are further complicated in the
setting of co-infections such as HIV where conflicting or synergist signaling can drive dysfunctional outcomes
including inflammation. Understanding how CLRs recognize and respond to microbial ligands to orchestrate
immune outcomes thus represents an important gap for understanding immune events and development of host
directed therapies. We identified a novel antimycobacterial role for the macrophage galactose type lectin (MGL,
CLEC10a), a CLR previously associated with alternatively activated (M2) macrophage outcomes in tumor
microenvironments. In preliminary outcomes, we have further identified that MGL is suppressed by Human
Immunodeficiency Virus (HIV) and loss of MGL leads to changes in the lipid response to Mtb associated with
defects in PPAR pathways. Our overall hypothesis is CLR signaling through MGL promotes metabolic
reprogramming of lung M through PPAR- pathways that alter lipid signatures and limit inflammation in TB.
Pulmonary M populations will be investigated to determine how MGL regulates the activation state and
functional response after Mtb infection. Our aims are to 1) Identify role of MGL to orchestrate the host lipid
response by pulmonary M populations following Mtb infection, 2) Demonstrate role of MGL pathways in
determining M polarization in response to mycobacteria, and 3) Identify the mechanism whereby MGL pathways
in lung M regulate Mtb-driven inflammation. We will employ mass spectrometry imaging, spatial transcriptomics,
lipidomics, and spectral imaging approaches in experiments with Mtb infected WT and gene deleted mice. We
expect our results to identify how MGL shifts myeloid cell metabolism toward an M2 activation state to limit
inflammation and regulate lipid accumulation. Long term, our findings are important for understanding M
activation states as affected by mycobacterial infections. Given our observations that MGL is susceptible to HIV-
mediated suppression, our results may further identify opportunities to augment myeloid cell function in those
with co-infections through host directed therapies.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will significantly advance our understanding of how the immune system regulates protective responses by myeloid cells in the lung following infection with Mycobacterium tuberculosis, the causative agent of tuberculosis. The results of these studies will identify ways to target the host immune lipid metabolism and inflammation to improve tuberculosis disease outcomes.